Proton-secreting epithelial cells as key modulators of epididymal mucosal immunity.

PROJECT SUMMARY/ABSTRACT
One of the most intriguing and understudied aspects of male reproductive physiology is the ability of the epididymis to
prevent the development of immune responses against autoantigenic spermatozoa, while initiating very efficient immune
responses against pathogens. The long-term goal of this application is to develop new strategic therapies for common
disorders such as male infertility and epididymitis, and to identify novel targets for male-contraception. The overall
objective is to elucidate how epididymal epithelial clear cells (CCs) communicate with immunocytes to contribute to the
“immune privileged” environment that is optimal for sperm maturation and storage. We have recently showed a
completely novel role for CCs in immune activation and sperm tolerance. Importantly, these cells establish intimate
contact with region-specific heterogeneous subsets of mononuclear phagocytes (MPs) in the epididymis. Our central
hypothesis is that CCs are strategically positioned to work in a concerted manner with immune cells to survey the
epididymis barrier and regulate the balance between inflammation and immune tolerance in the post-testicular
environment. The rationale is based on our preliminary data showing that CCs and MPs communicate in the steady state
epididymis and also in the presence of infection or injury, and that both cell types express different tolerogenic mediators
allowing the modulation of sperm tolerance. Therefore, these cells play a central role in the epididymal mucosa. In the
first specific aim, we will determine CC – MP communication networks that initiate immune activation during epididymitis.
In this aim, two mouse models of epididymitis will be used: injection of bacterial antigens into the cauda lumen, and
epididymal-testicular torsion that induces sterile inflammation. In the second specific aim, we will evaluate CC - MP
crosstalk after ablation of sperm tolerance in the epididymis, induced by depletion of regulatory T cells using diphtheria
toxin-based transgenic mice. The research proposed in this application will use an innovative multidisciplinary approach
that employs powerful immunology techniques rarely used to study reproductive physiology, 3D confocal microscopy,
transcriptomics analysis, flow cytometry, cell sorting and bioinformatic analysis, as well as the use of mouse models to
describe how specialized epithelial cells and immunocytes communicate in the epididymis. Notably, we will provide an in-
depth characterization of three specific epididymal cell types: CCs and two subsets of MPs. Our proposed research is
significant because it is expected to provide new insights into major immunoregulatory mechanisms by which epididymal
CCs together with MPs protect spermatozoa against harmful antigens and autoimmunity. Ultimately, such knowledge will
fill important gaps related to male reproductive biology by addressing crucial concepts of mucosal immunology and cell–
cell interactions, all of which are critical but understudied facets of human male reproductive health.

Public health relevance
PROJECT NARRATIVE The proposed research will provide new frameworks for the treatment of male infertility, a major public health concern, and identify targets for male contraception. Spermatozoa acquire motility and fertilizing power during their transit through the epididymis, a long tube located downstream of the testis. Our laboratory studies how epithelial cells work together with immune cells to protect spermatozoa against pathogens and autoimmunity and contribute to the immune- privileged environment of the epididymis. Thus, the proposed research is relevant to NIH’s mission to enhancing health and reducing illness.